Appalachian STAR Trial – Diversity Supplement

Diversity Supplement for Appalachian STAR Trial
M-PI: Susan Emmett, MD, MPH and Matthew Bush, MD, PhD, MBA
Project Summary/Abstract
Health disparities begin early in life, and schools often offer the only access to preventive services
for rural children; however, preventive screening programs are variably implemented, plagued by
loss to follow-up, and frequently compounded by limited access to specialists in rural areas. The
goal of the Appalachian STAR Trial is to establish a novel, generalizable model of school-based
telehealth-driven preventive care that can be disseminated to rural populations across America.
The Appalachian STAR Trial is currently wrapping up its third year, and valuable feedback from
participating school staff members and the Community Advisory Board (CAB) has led to the need
for supplemental research activities. The STAR model was adapted based on community member
feedback (Aim 1), and the enhanced hearing screening component of the stepped-wedge trial
(Aim 2) was rolled out in year three. An implementation evaluation (Aim 3) was conducted with 24
participants who used the STAR model. Based on overwhelming feedback, the intervention was
significantly redesigned, and a second year of the enhanced hearing screening component will
be conducted, including another implementation evaluation to assess the impact of modifications.
While iteratively adapting the STAR model, the CAB highlighted the need to concentrate efforts
on reaching historically marginalized communities, specifically Hispanic and Black communities,
with the goal of ensuring the STAR model intervention is accessible to families that are
linguistically and culturally diverse. To be responsive to the CAB’s directives, Aim 3 will be
expanded to include an increased emphasis on recruitment of those who are Hispanic and/or
Black. Based on community feedback, the specialty telemedicine component of the STAR model
will be iteratively evaluated with both groups to strengthen potential adoption of telehealth and
similar healthcare services for all eligible Kindergarten children. This supplemental research
activity will be conducted by a bilingual Hispanic research audiologist who is a recent graduate of
the University of Arkansas for Medical Sciences Audiology Program and joined the Center for
Hearing Health Equity as a postdoctoral fellow. Born and raised in Mexico with an interest in
advancing culturally and linguistically sound clinical and research initiatives within audiology, this
candidate is well-positioned to lead this project. Through this Diversity Supplement, the candidate
will receive mentorship in conducting community-based research in audiology, from design to
dissemination, with the goal of teaching the necessary skills to bring diverse perspective to clinical
research within the hearing sciences.

Public health relevance
Diversity Supplement for Appalachian STAR Trial M-PI: Susan Emmett, MD, MPH and Matthew Bush, MD, PhD, MBA Project Narrative Health disparities start early, and for many rural children, schools are the only place they can get preventive care, but access to these services is often inconsistent and limited. The Appalachian STAR Trial is developing a school-based telehealth program to improve access to care in rural areas. Based on community feedback, a new focus will be on ensuring the STAR model is culturally and linguistically inclusive to reach Hispanic and Black families.